Proteins important for dense-core vesicle function

The dense-core vesicle is an organelle that releases peptide hormones, growth factors, and biogenic amines
from neurons and neuroendocrine cells in response to increases in calcium. Dense-core vesicle cargos
regulate a variety of biological processes including neuronal survival and development, pain sensation, blood
glucose homeostasis, and synaptic plasticity. As a consequence, numerous diseases such as mood disorders,
obesity, and diabetes are caused by defects in neuropeptide and hormone secretion. Thus, it is important to
determine the molecular machinery and mechanisms that orchestrate the biogenesis and release of these
vesicular carriers. However, in comparison to other vesicular compartments such as synaptic vesicles, little is
known about the molecular mechanisms of dense-core vesicle biogenesis, trafficking, and release. Dense-core
vesicles are generated at the trans-Golgi and gain their compartmental identity in a poorly defined maturation
process that occurs post-Golgi, but few molecules have been identified that function in these processes. Cargo
sorting to dense-core vesicles remains a puzzle. The long-term goal of this project is to understand the
molecular mechanisms by which dense-core vesicles are formed, sort cargos, and gain their compartmental
identity. A first step towards this goal is to identify molecules required for dense-core vesicle biogenesis. We
performed a genetic screen in the nematode C. elegans for mutants defective in dense-core vesicle function
and identified a number of new proteins that act in dense-core vesicle biogenesis, including the small GTPase
RAB-2 and CCCP-1, a RAB-2 effector, as well as the EARP endosomal trafficking complex. In this project, we
will test how RAB-2 and its effectors interact with EARP to mediate cargo sorting to dense-core vesicles. In
Aims 1 and 2, we will use genetic, biochemical and cell biological approaches in C. elegans and in the
mammalian insulin-secreting cell line INS-1 832/13 to determine how and where the RAB-2 and EARP
complexes are localized, whether they physically and functionally interact, and determine their precise roles in
the sorting, processing, and secretion of dense-core vesicle cargos. In Aim 3, we will use a combination of in
vitro biochemical approaches and in vivo functional assays to determine how the golgin-like coiled-coil protein
CCCP-1 binds membranes and functions to mediate dense-core vesicle biogenesis. These studies will
advance our understanding of how dense-core vesicles are generated and sort cargos, and provide general
insights into mechanisms of membrane trafficking and cargo sorting controlled by multisubunit complexes that
mediate trafficking between endosomal compartments and the trans-Golgi network.

Public health relevance
Nerve and endocrine cells package chemical transmitters and hormones in a specialized compartment called the dense-core vesicle. Abnormalities in the packaging or release of these compounds can lead to a number of human mental and metabolic disorders such as schizophrenia, depression, attention deficit/hyperactivity disorder, eating disorders, obesity, and diabetes. By identifying the components required to make a normal dense-core vesicle and figuring out how they work, we hope to gain a better understanding of these diseases, paving the way for the development of new therapies.